Engineered T cell approaches for Alzheimer's disease

Project Abstract Chimeric Antigen Receptor (CAR) T cells have revolutionized the treatment of hematologic
malignancies, and recent clinical trials have also shown the potential of using CAR T cells against other
pathologies, such as autoimmune diseases. Despite the common notion of brain-immune privilege, the presence
of adaptive immune cells within the CNS has long been known to modulate cognition, suggesting that the immune
system might be a viable target for improving cognition. We and others have implicated interactions between the
CNS and the immune system in the development and progression of Alzheimer's disease (AD). T cells,
specifically, have a complex role in AD pathology, with both protective and destructive functions. The exact
mechanisms by which T cells convey pro-cognitive benefits remain poorly understood in many cases, although
cytokine release remains the prevalent theory. For example, we recently showed a mechanistic link between IL-
4 secretion by meningeal T cells, improved memory, and rescued synapse function, and a pro-cognitive role of
IL-4 has also been demonstrated in AD mouse models. While AD treatments using monoclonal antibodies have
shown efficacy in reducing the level of amyloid beta (Aβ) plaques, their effects on cognition are limited and more
powerful treatments are needed. Here, we propose an alternative approach in which amyloid beta (Aβ) plaques
and other AD-related brain antigens are utilized as AD-specific signals to home neuroprotective T cells that will
modulate the brain microenvironment to alter AD trajectories and improve cognition. In the Exploratory R61
phase, we will design and develop CARdinal (CAR Disease INterventions for ALzheimer's) T cells that are
programmed to expand and persist at the site of AD pathology by utilizing cytokine signaling in our CAR
constructs, rather than “classic” cytolytic CAR T cells. These T cells will release neuroprotective payloads that
we propose will support neuronal function and improve cognition. Given that IL-4 can modulate memory and
that BDNF can have protective effects in rodent and primate models of AD, we will engineer our CAR T cells to
secrete IL-4 and/or BDNF as proof-of-concept therapeutic cargos. If defined milestones for the R61 phase are
met, we will then pursue the Developmental R33 phase, in which we will test the hypothesis that repurposing
our novel CARdinal T cells towards a proliferation and cargo secretion function, rather than a cytotoxic trajectory,
will yield CAR T cells that are safe and effective for in vivo delivery of AD-therapeutic cargos to the brain with
minimal cytotoxic effects. We will use single-cell multiomic technologies to determine the CARdinal T cells’
mechanism(s) of action by measuring cellular interactions, spatial organization, and temporal transcriptional
changes in the CNS. We hypothesize that BDNF- and IL-4-secreting CAR T cells will significantly modify the
CNS microenvironment, specifically by reprogramming microglial gene signatures and cellular programs, thus
preventing cognitive decline. We expect that these studies will yield engineered neuroprotective CAR T cells that
are safe and effective for in vivo use in AD.

Public health relevance
Project Narrative: Alzheimer’s disease is a progressive neurodegenerative disorder with an unmet critical need for therapies that improve cognition. CAR T cell therapies have revolutionized the treatment of cancers by enabling the targeted killing of cancer kills. We propose to engineer brain-targeted neuroprotective CAR T cells that, instead of killing, will release molecular cargoes that support and protect neurons specifically at sites of Alzheimer’s pathology.